TESTICULAR CONTROL OF LH AND FSH SECRETION

The goal of this research is to elucidate the neuroendocrine mechanisms that govern testicular function in the rhesus monkey, a representative higher primate. The research proposed for the next 3 years will continue to address the action of testosterone to decelerate the frequency of intermittent GnRH secretion by the hypothalamus, which appears to be major mechanism underlying the negative feedback control of LH secretion by the testis. Experiments are proposed to identify the parameters of pulsatile testicular testosterone secretion (i.e. pulse frequency, pulse amplitude, integrated secretion rate) that determine, in a quantitative fashion, the intensity of the action of testosterone to retard the hypothalamic GnRH pulse generator. These studies may be expected to provide general insights into the significance of circulating pulsatile steroid profiles in determining the strength of negative feedback signals upon hypothalamic-pituitary function. In addition, studies are proposed to address the concern of the previous review group that the hypothalamic lesioned-GnRH replaced male monkey may not be an appropriate model for the study of the testicular regulation of gondaotropin secretion in primates. If the supremacy of the foregoing experimental paradigm is re-established by studies conducted during the first year of the proposal then the testicular regulation of FSH secretion will be further examined, with the specific aim of determining the nature and mechanism of action of the non-androgenic testicular factor that appears to suppress FSH secretion in the monkey directly at the level of the pituitary. These studies may necessitate the resurrection of the 'inhibin' hypothesis and may therefore lead to a better understanding of contraception in the human male. Pulsatile patterns of LH secretion, which will be determined by an estabished RIA and subsequently analysed by PULSAR, a computerized alogorithm for pulsatile hormone assessment, will be used to monitor the action of testosterone on the hypothalamic GnRH pulse generator. Chronic iv hormone (GnRH and testosterone) replacement regimens will be employed to mimic physiologic patterns of hormone secretion. Surgical procedures will be conducted using standard aseptic technique. When chronic access to the venous circulation is required, remote infusion-withdrawl devices will be employed that do not require either restraint or tranquilisation of the experimental primate. These studies will provide important new information on the neuroendocrine control of gonadotropin secretion in higher primates and may therefore have direct relevance to the regulation of fertility, and to the treatment of infertility, in man.